Biorepository

The UC Davis Cancer Center Biorepository was created in 2004 to provide quality cancer-related human biospecimens that are procured, stored and annotated using international standards of best practices and protocols that are Office for Human Research Protection (OHRP) compliant. The biorepository functions as a centralized tissue bank that provides all cancer center members with an efficient, high quality, stable, reliable, cost-effective access to cancer-related specimens and histology services. The specific aims of the Biorepository shared resource are: The primary objectives of the CCB shared resource are to facilitate cancer related research at UC Davis by 1 procuring, preparing, storing and dispersing human cancer-related biospecimens from a centralized cancer center biorepository; 2 providing pathological and clinical annotated data using a secure database (caTissue) 3 ensuring compliance with all mandated regulatory processes (HHS, IRB, HIPAA, SRC) thereby promoting ethical research by UC Davis researchers; 4 providing experienced pathologic consultation to investigators 5 efficiently prioritizing, tracking and dispersing biospecimen requests via a rapid, web-based approval and monitoring process 6 providing Tissue Microarray (TMA) construction and histology services for Cancer Center investigators The long-term objective of the CCSR is to facilitate scientific interactions and enhance scientific productivity by providing well-characterized, high-quality cancer-related specimens with annotated data for clinical and basic science research purposes.

Public health relevance
The resource provides tissue in various forms of storage as well as bodily fluids that are used in basic cancer research and in animal models of cancer to improve scientific understanding of tumors, tumor development, and anti-tumor therapies with benefit, ultimately, to how cancer patients are treated and cured of disease.